Social safety as a novel mechanism of risk for problematic substance use among sexual and gender minority youth

PROJECT SUMMARY
Sexual and gender minority (SGM) youth are at higher risk for problematic substance use compared to non-
SGM youth. This disparity persists into adulthood, when SGM adults experience a disproportionately higher
rate of substance use and disorder. Though such disparities are well established, few studies have examined
social determinants that may explain variation in substance use risk within SGM youth. Minority Stress Theory
suggests that variation in risk for substance use is due to individual differences in exposure to minority stress
(e.g., discrimination). Social safety (feelings of social inclusion and acceptance) may be a key mechanism
underlying the link between minority stress with substance use. Extant theory and research suggest that
heightened experiences of minority stress have a negative impact on social safety, indicated by chronic threat
vigilance. The proposed study seeks to investigate social safety as a mechanism explaining the heightened
rates of problematic substance use among SGM youth. Furthermore, this study investigates the impact of
protective factors that may disrupt this pathway and reduce substance use risk among SGM youth.
Identification of social safety mechanisms, as well as associated protective factors, can inform the
development of school-based programs, social services, and policies designed to specifically address
social safety as a protective factor against risk for substance use among SGM youth. With this NRSA
F31 proposal, the applicant seeks training to pursue a career as an independent clinical research scientist
focused on prevention of problematic substance use among SGM youth. Training goals address gaps in her
current doctoral program and include acquiring knowledge about theories, mechanisms, and methods for
studying developmental pathways for youth substance use and SGM disparities more specifically; expertise in
advanced longitudinal and integrative data analysis; and skills related to scientific writing and dissemination.
These skills will be applied to conduct a study examining within-SGM population heterogeneity and timing of
risk for substance use during youth development. Three aims will be investigated through integrated data
analysis of two seven-wave studies of SGM youth using an accelerated longitudinal cohort design to capture
development from ages 16 to 24. Data will be harmonized and pooled to meet psychometric standards before
analyses. Specific aims are to examine whether: 1) SGM youth with greater minority stress in adolescence
show greater decrements in social safety and, in turn, greater increments in problematic substance use into
young adulthood as compared to those with less minority stress, 2) for any given SGM youth, individual
periods of increased problematic substance use coincide with periods of greater minority stress and
decrements in social safety, and, 3) protective factors reduce risk of problematic substance use associated
with decrements in social safety across time and in period-specific elevations among SGM youth.

Public health relevance
PROJECT NARRATIVE Sexual and gender minority (SGM) youth are at higher risk for problematic substance use compared to non- SGM youth. This study investigates whether experiences of discrimination and marginalization among SGM youth decrease perceived safety in social contexts, and, in turn, exacerbate substance use. Identification of social safety mechanisms, as well as associated protective factors, can inform the development of school- based programs, social services, and policies designed to specifically address social safety as a protective factor against risk for substance use among SGM youth.